CRCNS: Neural circuits for egocentric and allocentric cognitive maps in humans

PROJECT SUMMARY (See instructions):
Cognitive maps allow humans to mentally represent their spatial environments and are thus essential for
navigation and memory in everyday life. Humans use different types of cognitive maps to guide their
behavior: egocentric cognitive maps, in which spatial information such as locations and directions is
encoded relative to the subject, and allocentric cognitive maps, in which spatial information is encoded
relative to the external world.
This project will use computational modeling and human single-neuron recordings in epilepsy
patients during a virtual-reality task to demonstrate the neural circuits that underlie egocentric and
allocentric cognitive maps in humans (Aim 1), guided by extensive research on spatial cells in animals.
Combining predictions from our computational models of navigation and memory with our prior discovery of
egocentric cells in the human medial temporal lobe, we will test for neurons that are egocentrically tuned to
boundaries, objects, and reference points and thus underlie egocentric cognitive maps. Going beyond our
description of human grid and place cells, we will also identify neurons that are allocentrically tuned to
boundaries, objects, and locations as the neural basis of allocentric cognitive maps. In tight feedback loops,
we will extend our computational models to integrate the empirical observations. Beyond navigation, we will
analyze and simulate how egocentric and allocentric spatial cells reactivate when humans use
cognitive maps to recall spatial memories (Aim 2). To show how cognitive maps become populated with
non-spatial information to generate complex memories, we will identify how spatial cells become linked
to neurons that represent non-spatial features to encode object location memories (Aim 3). We will
test empirically and investigate computationally whether sharp wave ripples play a role in the encoding and
retrieval of such complex memories by triggering synchronous activity in spatial and non-spatial cells.
Applying confined and diffuse neuron loss to our models, we will mimic memory disorders and examine
their effects on behavior.
Overall, this project will lead to new insights into the cellular mechanisms of spatial navigation and memory,
helping us to identify the working principles of the human brain. Our discoveries will be instrumental in
understanding the cognitive effects of mental illnesses, and they will provide the ground for developing
treatment options of memory disorders such as electrical brain stimulation to restore cognitive functioning.

Public health relevance
RELEVANCE (See instructions): Aging and brain disorders such as dementia and epilepsy lead to deficits in spatial navigation and memory, which are vital to daily functioning and independence. Here, we will identify key neural circuits of navigation and memory in humans, thus helping explain the cause of navigational disorders and memory deficits. This will support the development of navigational aids and guide future circuit-based interventions to alleviate memory loss, thus improving the lives of persons with memory deficits, disorientation, and mental illnesses.